Extracranial Carotid Atherosclerosis Contributions to Cognitive Impairment and Alzheimer's Disease Risk

PROJECT SUMMARY
Our parent award is designed as a prospective, observational study to understand the role of extracranial carotid
artery disease (ECAD) in Alzheimer’s disease and related dementias (ADRD) risk. One of the Aims is to evaluate
the effects of treatment of ECAD using carotid endarterectomy on ADRD risk. This work involves evaluation of
key blood-based and MRI-defined biomarkers associated with neurodegeneration and ADRD. These biomarkers
are evaluated longitudinally in subjects with ECAD, subjects without ECAD (controls) and subjects with ECAD
who have surgery. Improved safety profiles of carotid artery stenting as treatment for ECAD has led to significant
increases in this procedure. Using this cohort of patients who have ECAD and undergo carotid stenting, this
Supplemental award will evaluate whether carotid stenting (which leaves the plaque in place and has been
associated with increased microemboli) affects biology and biomarkers associated with ADRD risk.

Public health relevance
PROJECT NARRATIVE Growing evidence indicates extracranial carotid artery disease (ECAD) increases risk for ADRD and related pathophysiology. This supplemental award will evaluate how carotid artery stenting, which is now increasingly used to treat ECAD, may affect risk for ADRD and associated pathology.